Novel Algorithm and Data Strategies to detect and Predict atrial fibrillation for post-stroke patients (NADSP)

Project Summary
Atrial fibrillation (AF) is the most common arrhythmia, affecting 33.5 million people globally with a
growing prevalence. AF is associated with significant morbidity and mortality, including 20% of all
strokes, 33% of hospitalizations related to cardiac arrhythmias, and a two-fold increase in risk of
death. To reduce AF-associated risks such as stroke, it is important to be able to diagnose AF early in
the AF trajectory when it is asymptomatic and paroxysmal in order to initiate effective stroke
prevention interventions including anticoagulation. Unfortunately, it is estimated that 700,000 people
in the USA may have previously unknown AF, and newly detected AF at the time of stroke was found
among 18% of AF-associated stroke incidents. Plethysmography (PPG) measures pulsatile blood
volume changes and is available in up to 71% of consumer wearables. Because of this unmatched
availability, PPG-based AF detection is ideally poised to enable low-cost, long-term, and continuous
AF monitoring at scale. However, modest performance of PPG-based AF detection when PPG
signals do not have perfect signal quality remains a critical impediment to fully realize its potential as
an AF-monitoring tool at scale. The proposed study aims to overcome this challenge by pursuing the
following aims: 1) design, develop, and validate a novel deep neural network (DNN) architecture that
integrate PPG signal quality assessment with AF detection to accurately detect AF even for signals
with imperfect signal quality; 2) validate and test further personalization of the proposed DNN using
prospective data from post stroke patients to be collected in ambulatory settings; 3) develop and
validate interpretable EHR-data driven machine learning approaches to identify patients with elevated
risk of AF for whom PPG-based AF monitoring can be most likely beneficial.

Public health relevance
Project Narrative Atrial fibrillation (AF) is the most common arrhythmia, affecting 33.5 million people globally with a growing prevalence. AF is associated with significant morbidity and mortality, including 20% of all strokes, 33% of hospitalizations related to cardiac arrhythmias, and a two-fold increase in risk of death. To reduce AF-associated risks such as stroke, it is important to be able to diagnose AF early in the AF trajectory when it is asymptomatic and paroxysmal in order to initiate effective stroke prevention interventions including anticoagulation. We propose an integrated data and algorithm strategy as well as a prospective study to fully exploit and validate the power of deep neural networks, interpretable survival models, and Big Data to achieve both high sensitivity and precision in using photoplethysmography (PPG) to detect AF and to use EHR data to identify patients with high risk of AF post stroke to benefit from continuous AF monitoring.